Therapeutic potential of psilocybin on stress-cued reinstatement

PROJECT SUMMARY
Opioid use disorder (OUD) and Post-Traumatic Stress Disorder (PTSD) are highly comorbid and mutually
exacerbating. There is a critical unmet need for pharmacotherapeutics targeting stress-precipitated relapse, as
stress-conditioned stimuli are a major driver of relapse in comorbid patients. Classical psychedelics like
psilocybin are appealing candidates as therapeutics for OUD, as they do not lead to physical dependence and
demonstrate promising potential in reducing stress and addictive behaviors in humans. These effects appear to
be long-lasting from one to few treatments, suggesting adaptation to neural circuits affected by chronic stress
and substance use. Despite promising clinical evidence suggesting the efficacy of psychedelics in the
treatment of stress and substance use disorders, there is a critical gap in the preclinical profiling of
psychedelics in OUD models. Understanding the neural mechanisms underlying the therapeutic effect of these
compounds is necessary for future development of novel OUD therapeutics with reduced hallucinogenic side
effects. We have developed a novel mouse model for studying relapse induced by cues associated with prior
stressful life events. My preliminary data from the Smith Laboratory demonstrate that the psychedelic
2,5,dimethoxy-4-iodoamphetamine (DOI) blocks stress-cued reinstatement to heroin in mice. We identified the
anterior insular cortex (aIC) as a brain structure that may mediate the interaction between psychedelics, stress,
and OUD, and find that DOI reduces reinstatement-induced c-Fos in the aIC. We propose that psychedelic-
induced plasticity promotes lasting adaptations to circuitry affected by stress and heroin seeking, resulting in
an attenuation of stress-cued heroin seeking. Aim 1 will identify the whole-brain pattern of neuronal activity and
behavioral effect of psilocybin on stress-cued reinstatement to heroin. Using cell-type specific circuit
manipulation via chemogenetics, we will gain valuable insight into the necessity of aIC 5HT2AR in modulating
stress-cued reinstatement to heroin. Understanding the role of the 5HT2AR, which mediates hallucinogenic
activity of psychedelics, in the therapeutic effects of psychedelics will provide critical information to steer drug
discovery efforts aiming to treat stress and substance use disorders with serotonin agonists. Aim 2 will use
fiber photometry to record aIC calcium dynamics during a stressful experience and re-exposure to stress-cue,
and determine how treatment with psilocybin impacts these responses. Together, these experiments seek to
elucidate circuit mechanisms underlying the effect of psilocybin on stress-induced heroin seeking behaviors.
This study will be conducted at the Medical University of South Carolina, a leading center in the field of
addiction neuroscience. Under the mentorship of Drs. Alexander Smith and Christopher Cowan, I will receive
training in rodent intravenous drug self-administration, whole brain c-Fos mapping, chemogenetics, in vivo
recording of neural activity with fiber photometry, and computational tools for data analysis.

Public health relevance
PROJECT NARRATIVE Opioid use disorder is a prevalent public health problem, and despite efforts to understand the neurocircuitry underlying relapse, there are currently no effective treatments specifically targeting relapse. This proposal aims to understand the neurobiological mechanisms underlying the effect of psychedelics on addiction- and stress- related behaviors, gathering preclinical evidence for a novel pharmacotherapeutic intervention for opioid use disorder. This project will also provide beneficial training in behavioral, molecular, and cellular neuroscience.